Identifying Chronic Pain Phenotypes and Treatment Disparities in Adults with Cerebral Palsy

Summary/Abstract
Cerebral Palsy (CP) is the most common pediatric-onset physical disability, with an estimated prevalence
ranging from 2.6-3.1 cases per 1,000 live births in the United States. There is a lack of clinical follow-up for
patients with CP after they transition from pediatric to adult primary care, and insufficient cohort data to track
clinical outcomes longitudinally. Pain is the most commonly reported somatic symptom in CP throughout the
lifespan, and yet chronic pain is perhaps the least understood, emphasized, and studied physical comorbidity
of CP. Pain in CP may arise from nociceptive mechanisms associated with chronic muscle spasticity, joint
misalignment, and invasive and repetitive surgical procedures. Alternatively, neuropathic pain could be a
consequence of periventricular leukomalacia, which causes dysfunction of non-nociceptive sensory tract
neurons in the majority of patients with CP. To date, there have been virtually no investigations to understand
the pain phenotype distribution and treatment disparities among adults living with CP, and how differing pain
management strategies contribute to physical and psychological morbidity and multimorbidity. Understanding
the phenotypes of chronic pain among adults with CP is crucial for prescribing the most appropriate and
effective pain management interventions. This innovative study proposes to examine the risk of pain and
multimorbidity among adults with CP as compared to adults without CP, and to further understand the role of
race/ethnicity and insurance type (Medicare vs. private) on pain management. Although understanding the
mechanisms of pain among adults with CP is crucial for prescribing the most appropriate and effective pain
management interventions, many adults with CP currently receive opioid prescriptions. Therefore, it is vital to
also examine the short and long-term effects of these analgesics and alternative treatments/therapies on long-
term health outcomes in this population. It is also critical to examine the extent to which mismanaged pain
mediates the trajectories leading to chronic morbidity and multimorbidity in this population. The study we
propose herein fills this critical gap in knowledge by leveraging several unique datasets representing a
population-representative sample of federally- and privately insured beneficiaries of U.S. adults with CP. Our
objectives, foundational to developing such targeted interventions, are to compare the prevalence and
incidence of chronic nociplastic, neuropathic, and nociceptive pain among privately and federally insured adults
with CP throughout the U.S (Aim 1); and quantify the mediating effect of chronic pain and opioid prescribing
patterns on physical and mental health morbidity and multimorbidity among persons with CP (Aim 2). Lastly
Aim 3 will determine the disparities in and effectiveness of pain management/treatment strategies by
race/ethnicity and insurance type, taking into account the social determinants of health. Data generated from
this study will lead to new knowledge pertaining to the natural history and trajectories of pain, morbidity
clusters, and healthcare disparities among adults with CP.

Public health relevance
Project Narrative Chronic pain is the most common symptom in adults living with cerebral palsy (CP), and yet it is one of the least understood and poorly treated comorbidities, especially among under-represented minority populations. Many adults with CP are prescribed opioid medications for pain management, and there is a high risk of abuse and related mental health disorders. The proposed research will examine the causes and consequences of chronic pain among adults with CP and explore treatment disparities across minority subpopulations.